Validation of the Yucatan Minipig as a Preclinical Model for Wrist Bone Arthroplasty

ABSTRACT
The goal of this proposal is to establish the Yucatan minipig as a preclinical animal model for innovative
therapeutics and arthroplasties designed to treat carpal bone pathologies associated with ligament injuries and
severe osteoarthritis (OA). Degenerative and traumatic wrist pain is common, often resulting in activity
restrictions and the inability to work. Ultimately, wrist replacement is the only treatment capable of retaining
wrist function while counteracting the degenerative changes. However, outcomes after wrist arthroplasty
treatment are much poorer than those for the hip, knee, or shoulder. Treatments for wrist osteoarthritis have
evolved much more slowly than these larger joints, due in large part to the lack of study and available data.
The wrist’s complexity also presents a significant challenge, compounded by the lack of a validated preclinical
animal model that can be used to interrogate the consequences of carpal instability and evaluate the ability of
carpal bone replacements to restore carpal function and limit osteoarthritis progression. Preclinical large
animal models have been crucial for the development, translation, and FDA approval of arthroplasty devices
for hips, knees, and spines. With an aging and increasingly active older population, the need for improved
treatments for degenerative wrist pathologies is growing rapidly. Accordingly, the goal of this proposal is to
establish the Yucatan minipig as a model for carpal bone therapeutics and arthroplasties that are designed to
treat severe osteoarthritis. This goal will be achieved in two independent aims. In the first, we will quantify the
biomechanics of the minipig carpus and the kinematics of the radial carpal bone (RCB) using established in
vitro biomechanical testing. In the second, we will evaluate OA progression in vivo, after induced carpal
instability and after treatment with a carpal bone hemiarthroplasty. In both aims three carpal conditions will be
evaluated, with the intact carpus as a reference: division of the radial intermediate ligament (RIL group),
division of the RIL+dorsal intercarpal ligament (RIL+DIC group), and hemiarthroplasty of the radial carpal bone
(RCBH group). Outcome measures for Aim 1 will include wrist biomechanics and radial carpal bone
kinematics. Outcome measures for Aim 2 will include spatiotemporal measurements of gait and cartilage
health. At the conclusion of this R21 project, we will, for the first time, have fully characterized the
biomechanics of the porcine carpus and we will have established a novel animal model for carpal bone
hemiarthroplasty and innovative therapeutics. This project will advance the treatment of carpal instabilities by
providing a fit-for-purpose animal model capable of evaluating important features of innovative treatments and
arthroplasty designs (e.g., shape, material, finish, bearing surfaces, fixation methods, bone/soft tissue
ingrowth, and wear debris), as well as the broad range of future innovative therapeutics, such as tissue
engineered ligaments, cartilage and osteochondral grafts, and patient-specific 3D printed implants.

Public health relevance
Narrative Severe wrist osteoarthritis is exceedingly common, but the currently available treatments are much less successful than those available for hip, knee, or shoulder arthritis. The ability to advance novel technologies to the clinic requires data from fit-for-purpose large animal models, thus the goal of this proposal is to validate the Yucatan minipig as a preclinical, large animal model of the wrist. The Yucatan minipig wrist model will provide a critically needed tool for the rapid development of next-generation wrist implants and biologics for the treatment of severe wrist osteoarthritis.